IGF::OT::IGF: PLANNING MEETING ON SOCIOECONOMIC STATUS AND INCREASING MID-LIFE MORTALITY

This planning meeting is relevant to NIA initiatives on U.S. and international geographic differences in health, national disability trends and dynamics, the recent trans-NIH FOA on Education and Health (PAR-16-080), and NIA initiatives on health disparities. In addition, this activity would support several NIA Strategic Goals: Goal B to “Better understand the effects of personal, interpersonal, and societal factors on aging, including the mechanisms through which these factors exert their effects”; Goal C to “Develop effective interventions to maintain health, well-being, and function and prevent or reduce the burden of age-related diseases, disorders, and disabilities”; and Goal F to “Understand health differences and develop strategies to improve the health status of older adults in diverse populations.